Macrophage Plasticity in Inflammatory Lung Injury

RESEARCH SUMMARY/ABSTRACT OF PROGRAM
The fundamental challenge in treating the hyper-inflammatory state underlying Acute Lung Injury/Acute
Respiratory Distress Disorder (ALI/ARDS) is that broad anti-inflammatory interventions could compromise host
defense and potentially exacerbate the underlying infectious process that triggered ALI/ARDS. Novel targeted
approaches to treat ALI/ARDS thus require an in-depth understanding of the intricate inflammatory mechanisms
to reduce the extent of injury and promote the resolution of inflammation as well as the initiation of lung repair
without compromising host defense. It is now recognized that macrophages (Mφ) in lungs represent diverse
multi-functional cell populations. They have the ability to sense pathogens and danger signals, and their plasticity
and diversity allows them to respond in specialized manners to specific niche environments. They are able to
change their phenotypes in a chameleon-like manner by activation of specialized transcriptional programs. Thus,
they have the remarkable ability to amplify inflammation and also to coordinate resolution of lung inflammatory
lung injury and restore homeostasis. Mφ carry out these functions through the release of an array of cytokines,
phagocytosis of microbes, efferocytosis of dead cells, and provide the essential inflammatory or reparative
signals to nearby cells. The central focus of this program will be to precisely define the roles of distinct
macrophage subpopulations in inflammatory lung injury and signaling nodes to harness the plasticity of
macrophages and thereby bring about the resolution of lung injury. Project 1 will test the hypothesis that two
specific specific ion channels, P2RX7 (Purinergic Receptor 2 subtype X7) and the potassium (K+) efflux channel
TWIK2 regulate the plasticity to either promote lung injury or to activate the repair program. Project 2 will test
the hypothesis that the transcription factor CREB and its downstream targets are critical regulators of the anti-
inflammatory and reparative function of alveolar Mφ. Project 3 will test the hypothesis that endothelial cells lining
all lung vessels direct the plasticity of Mφ via modulation of Wnt signaling in Mφ. Project 4 will test the
hypothesis that circulating postnatal CX3CR1+ monocytes replenish lung interstitial Mφ during inflammatory
injury and can direct the lung tissue repair program. These four Projects are supported and complemented by
highly innovative scientific Cores which will provide important optogenetic tools (Synthetic Biology and
Optogenetics Core B), super-resolution and intravital imaging (Advanced Imaging Core C), and access to
clinical samples as well as single cell transcriptomic analysis of macrophages (Clinical Sampling and
Genomics Core D) to unravel the complexities of macrophage biology in lung injury, thus paving the way for
much-needed novel therapeutic approaches in ALI/ARDS.

Public health relevance
NARRATIVE The immune system protects lungs during infections but sometimes an excessive and unchecked immune response can destroy the lungs, resulting in acute lung injury (ALI) or its more severe form referred to as acute respiratory distress syndrome (ARDS). Macrophages are immune cells which can either enhance inflammation or instead dampen inflammation and bring about the repair the lung, depending on the type of macrophage. The proposed research program is focused on harnessing the plasticity of macrophages to increase their repair function and thereby set the foundations for future treatments to prevent lung damage during infections.